Cell Cycle Control Of Arterial-Venous Specification Within the Developing Embryo

Project Summary:
The blood vascular circulatory system is composed of arterial, venous, and capillary vessels, which work
together to facilitate the efficient exchange of gasses, nutrients, and waste from all tissues, while regulating blood
pressure and distribution of immune cells. The endothelial cells that line these vessels must acquire specialized
characteristics to enable specialized arterial, venous and capillary functions, a process known as endothelial cell
specification. Disruption of this process during development can lead to embryonic lethality, while postnatally it
causes arterial-venous malformations and contributes to pathological conditions, including dysfunctional tumor
vasculature. Understanding the mechanisms that control arterial-venous endothelial cell specification and
network formation is essential for advancing our ability to improve therapies for vascular pathologies,
revascularize injured tissues, and optimize the differentiation of pluripotent human stem cells for vascular tissue
engineering and regenerative medicine therapies.
Our previous studies, in the postnatal murine retinal vascularization model of sprouting angiogenesis,
revealed a critical role for blood flow-regulated endothelial cell cycle state in their fate specification. We found
that arterial/arteriolar shear stress levels promote Notch signaling, and downstream p27-induced late G1 state,
which enables TGF-β1-induced arterial gene expression (Fang 2017; Chavkin 2022). Conversely, flow
magnitudes typical of veins/venules induce early G1, which enables BMP4-induced upregulation of venous
genes (Chavkin 2022). However, blood flow is not required for the initiation of arterial-venous specification during
embryonic vascular development (Chong 2011), and whether endothelial cell cycle control is required for this
process is unknown. I hypothesize that endothelial cell cycle control is required for embryonic arterial and
venous specification and its dysregulation causes arterial-venous malformations. In support of this, my
preliminary data show that, during embryonic vascular development, even before flow, arterial endothelial cells
are enriched in late G1, while venous endothelial cells are enriched in early G1. Additionally, we identified target
genes that may regulate endothelial cell cycle state and/or specification. Using the Fucci2 cell cycle reporter
mice, we will rigorously define the cell cycle state of arterial and venous endothelial cells in the developing
embryo and determine the role of endothelial cell cycle control in fate specification. We will also identify novel
key regulators of endothelial cell cycle state and arterial-venous fate that can provide new targets for the
treatment of diseases associated with endothelial cell hyperproliferation and loss of identity, including vascular
malformations and tumor angiogenesis.

Public health relevance
Project Narrative: Defects in endothelial cell specification causes embryonic lethality, vascular malformations, and contributes to many diseases; however, the mechanisms regulating endothelial cell specification are poorly understood. We propose that cell cycle control is necessary for proper endothelial cell specification and that its loss will lead to immature and malformed vasculature. Completion of these studies will reveal novel mechanisms that regulate arterial and venous vessel formation, which will aid in the creation of clinical and regenerative therapies for vascular pathologies.